MOLECULAR GENETIC BASIS OF WILLIAMS SYNDROME

This study is designed to examine the cognitive sequellae of Williams syndrome and to determine the genetic basis for the cognitive defects. Geno/phenotype correlations are being performed by collecting detailed clinical information on patients studied at the Salk Institute and obtaining blood from them for molecular studies. Lymphoblastoid cell lines are being established by the GCRC, ensuring that adequate quantities of DNA will be available for the detailed molecular evaluations of 7q11.2. Patient accrual will continue in the coming year.